BLR&D Merit Review Research Career Scientist Award Application

As the general population and veterans age, their hearts will undergo dramatic changes, reducing their
capacity to work efficiently and increasing their susceptibility to injury. In addition, there are several co-
morbidities such as diabetes that ensue with age that will further impact the heart and its adaptation to stress.
Interventions that help to protect the heart from injury are likely to be useful in patients at high risk for
cardiovascular events. Along with the general population, as veterans age, there will be an increasing burden
of healthcare associated with age that lead to cardiovascular dysfunction. There are a number of molecular
targets that may be critical in protection of the myocardium to stress but a unifying factor has been elusive, and
thus a pharmacologic target not well defined. Multiple pathways of stress adaptation share an interconnected
mediator that may be targeted therapeutically. The Patel Laboratory has focused on identifying novel and
unique mediators that regulate many pathways and may be viable therapeutic endpoints for cardiovascular
disease. The laboratory has a specific interest in caveolin protein. There is clear clinical implication and need
for interventions that limit the severity of injury that occurs to the myocardium, as this is a major risk factor to
morbidity and mortality. Interventions that help protect the heart are likely useful in many patients. Also, the
basic nature of the studies underway in the Patel Laboratory to understand the fundamental physiology of the
cell may be broadly applicable to other organs and disease systems including but not limited to cancer biology,
neurodegeneration, nephrology, urology, muscle physiology, pulmonary diseases, and the biology of aging.
The Patel Laboratory has explicitly been interested in assessing the impact of caveolae, membrane
microdomains enriched in lipids and the structural protein caveolin, on cardiac physiology and pathophysiology
for over a decade. Ongoing and collaborative studies with other national and international institutions has
resulted in expansion in multiple organ systems and the potential to translate basic findings to several clinical
problems. In 2004, Dr. Patel performed a simple experiment in which caveolae disruption showed that
ischemia- and opioid-induced cardiac protection was lost. This single experiment launched further inquiry into
defining the role of caveolae in the heart, especially as it relates to disease pathology; this was the initial
research funded by a Scientist Development Grant from the American Heart Association. The laboratory has
sustained and expanded this focus over the years to uncover fundamental biology, define the role of caveolae
in cardiac disease, and develop tools to target this therapeutically. The Patel Laboratory has also uncovered
caveolin's specific, critical, and interconnected role in regulating cellular metabolism, which is being applied to
more complex studies related to neuroscience, cancer, diabetes, aging, and renal biology. A licensed patent is
being developed as a therapeutic for ALS, and clinical trials are expected to commence in the coming year.
These advancements have positioned the laboratory as a leader in connecting structure to physiology in
caveolin biology.
Recent studies funded by a 5-year, $10M gift from the InnerScience Research Fund has launched a new area
of mind-body research in the Patel Laboratory applying sophisticated biochemical, molecular, cell biology, and
physiological measures to determine how the mind adapts that body to stressors during immersive meditations
(IRB managed offsite by clinical group). The studies involve large cohorts (3000+ subjects, many veterans
have participated) with multi-omic profiling. Dr. Patel leads a group of physicians and basic scientists to
uncover this unique biology that has significant implications for veteran health.

Public health relevance
As the general population and Veterans age, their hearts will undergo dramatic changes reducing their capacity to work efficiently and increase susceptibility to injury. Veterans also experience several diseases (i.e., diabetes, kidney failure, liver disease, etc.) that will all impact directly or secondarily to dysfunction in the heart. The research performed in the Patel Laboratory determines to understand novel mechanisms for stress adaptation in the heart. These mechanisms will allow identification therapeutics for heart disease to limit the morbidity and mortality linked to cardiovascular disease. There is clear clinical implication and need for interventions limiting the severity of injury to the myocardium during stress in the setting of age. Interventions that help to protect the heart may be useful in patients undergoing surgery, especially those at high risk for cardiovascular events. The research has the broad potential to impact healthy aging in the Veteran population in several areas, including but not limited to cancer biology, neurodegeneration, and vascular biology.